Developing Dissemination Strategies to Advance the Reach of T1D Psychosocial Care

Adolescents with type 1 diabetes (T1D) experience worse T1D health outcomes (higher glycemic levels, greater psychological distress) compared to their adult counterparts. Evidence-based pediatric T1D psychosocial care has the potential to improve diabetes distress, high glycemic levels, and family conflict. However, few families are aware of or receive this needed care. To increase the reach of this care requires both implementation strategies to ensure what is delivered in standard care is evidence-based, as well as dissemination strategies to increase family knowledge, engagement, and utilization of this care. Dissemination efforts must include viewpoints from a wide range of families to improve care for all. The proposed study is the first to develop family-focused dissemination strategies for evidence-based T1D psychosocial care. Guided by Lavis’ Framework for Knowledge Transfer, the current community-engaged study will be conducted with the PIs existing pediatric T1D Family (adolescents with T1D, caregivers) and Provider Partners (REACH Pilot) who will guide refinement and execution of the proposed research plan from study design through dissemination. The PROMISE Core and content experts on dissemination science (Becker), mixed methods (Deatrick) and pediatric behavioral intervention (Kazak), as well as Nemours and Breakthrough T1D Social Media Specialists (Nunery, Gottlieb) will support the execution of this research. Dr. Price, the PI, will use surveys to gather perspectives from adolescents with T1D and their caregivers on preferences related to (1) What should be disseminated, (2) To whom, (3) By whom, (4) How, and (5) With what effect (Aim 1). Individual interviews with adolescents and caregivers will be used to refine quantitative data from Aim 1 and to select and tailor dissemination tools (Aim 2). After viewing newly created dissemination tools and content, adolescents with T1D and caregivers will complete surveys on the clarity, reach, influence, and trustworthiness of these tools and strategies (Aim 3). This foundational study will result in family-centered, ready-to-test dissemination strategies, which will bolster an R01 application to conduct a multi-site randomized trial testing dissemination strategy effectiveness on increasing families’ knowledge, engagement, and utilization of evidence-based T1D psychosocial care. Such work complements Dr. Price’s ongoing research on implementation science (K23 from NIDDK). With her community partnerships and complementary implementation data, the proposed dissemination project will advance her goals to become an independent investigator and improve T1D healthcare and outcomes among all adolescents with T1D.

Public health relevance
Adolescents with type 1 diabetes (T1D) exhibit significant difficulty completing the complicated treatment regimen for T1D, placing them at risk for adverse acute and long-term health outcomes. Although evidence-based psychosocial care is efficacious at improving health outcomes for adolescents with T1D, few families are aware of or receive this care. This project aims to create effective dissemination strategies, or methods for increasing the spread of information about the latest psychosocial care science, to increase family knowledge, engagement, and utilization of psychosocial care that matches their needs, improving the overall health of adolescents with T1D.